Molecular interactions of histone ubiquitylation enzymes with the nucleosome

DESCRIPTION (provided by applicant): The post-translational modification of histone proteins is now established as an important mechanism for regulating gene expression in eukaryotic cells. However, a structural and mechanistic understanding of how the histone modification enzymes function on their nucleosome substrate is lacking. This shortcoming limits interpretation of the wealth of genetic, genomic and biochemical data available, and it hampers development of new therapeutics that target the many chromatin enzymes associated with human diseases including cancer. To address this deficiency, we propose to study how the PRC1 polycomb repressive complex conjugates ubiquitin to histone H2A assembled in nucleosomes. The addition of ubiquitin to histone H2A has significant biomedical consequences: mono-ubiquitylation of histone H2A by PRC1 plays a critical role in embryonic stem cell maintenance, while mono-ubiquitylation of histone H2A by BRCA1 may mediate this breast cancer protein's tumor suppressor function. This proposal focuses on the following two specific aims: 1. Determine structure of the PRC1 ubiquitylation module on the nucleosome. We propose to crystallize the E2/E3 ubiquitylation complex of UbcH5c/Ring1/Bmi1 in complex with the nucleosome core particle and to determine the atomic structure of the complex by X-ray crystallography. 2. Elucidate mechanism for PRC1 module ubiquitylation of nucleosomes. The crystallographic studies will be complemented by biochemical studies to analyze the roles of the UbcH5c E2 ubiquitin-conjugating and the Ring1b/Bmi1 E3 ubiquitin ligase proteins in ubiquitylating nucleosomal H2A.

Public health relevance
PUBLIC HEALTH RELEVANCE: In our cells, our DNA genetic information is packaged with histone proteins into chromatin. Recent studies have shown that histone proteins can be decorated by histone modification enzymes with small molecules or proteins, and these decorations regulate gene expression in normal and diseased cells. Our studies will visualize how the ubiquitin ligase class of histone modification enzymes associated with stem cells and cancer perform its function.